Regulation and Significance of Sustained Circadian Oscillations

Project Summary/Abstract
Circadian (daily) rhythms are a crucial component of human health that regulates sleep, alertness,
homeostasis, cellular signaling, and many other biological processes. The fascination of this phenomenon is to
explain how a biochemical mechanism (i) can robustly sustain a long period (~24 h) oscillation whose
frequency keeps time so precisely, and (ii) enhance fitness in the natural environment. These questions remain
critically important unanswered issues in the circadian rhythms field. For example, the adaptive value is not
clear for the most obvious circadian characteristic–a robust self-sustained oscillation in constant conditions. If
“anticipation” of future temporal events (e.g., dawn, dusk, etc.) is the goal of circadian timekeepers, why is a
temperature-compensated “hourglass timer” that is initiated by dawn or dusk not sufficient? And yet evolution
ubiquitously selected an oscillator that sustains itself in non-natural continuous conditions as the timekeeper for
regulating daily processes, and this characteristic forms a core defining property of circadian rhythms. The
overall goal of this project is to determine which characteristics of rhythmic environments provide selective
pressures that coordinate cellular organization of gene expression and information processing to promote
properties of circadian timekeeping. Identifying the selective pressures & evolutionary steps that can lead to
biological timekeeping will enable a more profound understanding of circadian mechanisms and signaling so
that they might be reinforced to aid human health and performance.
The unique characteristics of model systems will be harnessed to attain the goal of this project by a
multifaceted approach. First, in free-living organisms, the circadian regulation of seasonal responses and
circadian interactions within communities of cells will be investigated to determine why sustained oscillators are
necessarily adaptive. Second, the temporal dimensions of host/microbiome relations will be manipulated to
ascertain if the gut microbiome is under active selection for timekeeping ability. Finally, a novel experimental
evolution approach will identify which environmental pressures can be selective for circadian clocks.
The answers to these questions will help us to better understand general principles of fundamental
circadian organization and rhythmic regulation of cellular physiology; this understanding can help us to better
design therapies for disorders in which circadian clocks are implicated.

Public health relevance
Project Narrative RELEVANCE TO PUBLIC HEALTH: This project will clarify the characteristics of circadian systems that enhance fitness. Biological clocks have been found to be crucial for physical and mental health; cancer, growth/proliferation, metabolic disorders, cardiovascular disease, and depression are associated with the disruption of these timing systems by genetic and/or environmental disturbance (i.e., by shiftwork or "jet-lag"). Understanding the crucial features of biological timing that are selected by rhythmic environments will reveal underlying circadian organization & regulation to assist the development of therapies to properly phase sleep, enabling us to improve the health, performance, and well-being of humans suffering from mental and/or metabolic disorders.